Viral Testing

PROJECT SUMMARY/ABSTRACT:
Continuous testing for certain viruses that can compromise HIV research results, is essential in any SPF Program
used for this purpose. The CPRC-SPF colony is free and systematically assayed for Simian immunodeficiency
virus (SIV), Type D Simian retrovirus (SRV-D) and Simian T-lymphotropic virus (STLV-1). The colony is also
free of Herpes B virus, which represents an occupational health risk for the personnel handling the animals. The
primary purpose of the virology testing arm of CPRC-SPF breeding program is to assure that its Indian-origin
rhesus macaque colony, supporting NIH-sponsored research specially on HIV/AIDS, is free of the above-
mentioned viruses. An advantage of this program is that it has been closed to external individuals since 2016.
Certainly, this aspect substantially decreases the risks of the re-introduction of any of the four tested viruses from
an external source. The specific aim of the Viral Testing Core is: Sustain the implementation of the reliable viral-
testing algorithm to continue producing high quality SPF animals with a well-defined virological status in
support of PHS-NIH sponsored biomedical research, especially HIV/AIDS studies.

Public health relevance
NARRATIVE: The primary purpose of the virology testing arm of CPRC-SPF breeding program is to assure that its Indian- origin rhesus macaque colony, supporting NIH-sponsored research specially on HIV/AIDS, is free of Simian immunodeficiency virus (SIV), Type D Simian retrovirus (SRV-D), Simian T-lymphotropic virus (STLV-1) and Herpes B virus. Testing is conducted by using the state of the art methodologies.